LYMPHOCYTE IMMUNOREACTIVITY AFTER DISCONTINUATION OF SIROLIMUS, TACROLIMUS, OR C

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The rate of return of lymphocyte reactivity over time as clinically relevant immunosuppressive drug levels fall in normal subjects is the primary end point. Cross group comparisons among the target agents as to degree of inhibition of mitogen stimulation at various time points is a secondaryend point.